(PQ1) The role of cell-to-cell variation in the penetrance of heritable mutant RAS hypodermal neoplasias

Project Summary: Our goal is to provide answers to the question: “What molecular
mechanisms influence disease penetrance in individuals who inherit a cancer susceptibility
gene?”. We plan to answer this question in terms of genetics and cell biology. More specifically,
we plan to identify which genes influence the penetrance of RAS-driven neoplasia, and then
observe how these genes alter the stereotyped program of gene expression and cell division by
directly observing gene expression and cell division with quantitative light microscopy.
Children with Noonan or Costello syndromes are born with mutations in RAS, the most
common oncogene. Some, but not all of these individuals develop cancer. RAS-driven cancers
are notoriously difficult to treat. Current anti-HSP90 clinical trials show some promise, but the
drugs are toxic. We have evidence that other chaperones may be suitable targets for
suppressing Ras-based cancer formation. We have evidence that the molecular mechanism
that influences Ras-driven neoplasia penetrance is the epigenetically heritable ability to express
more or maintain more biologically active molecules of protein per unit gene.
In the proposed research, we will study isogenic C. elegans with a Ras gain of function
allele that results in incompletely penetrant hypodermal neoplasia. When these animals inherit a
gain of function mutation in their sole Ras homolog, let-60, just like children with Noonan
syndrome, some of them will develop neoplasias. About 90% of Ras oncogene bearing worms
will acquire 1-4 hypodermal neoplasias during development, in response to conserved, cancer-
related EGF, Notch and WNT signaling pathways. In worms with wild-type Ras, these pathways
would normally control organogenesis of the vulva. The initial manifestation of neoplasia
happens reliably, at the same time during development, over and over – right when the signal
for vulva development happens. We have a system wherein we know exactly where and when
to look, so we can see exactly what happens in cells that may or may not become neoplastic.
We will perform a reverse genetic screen to identify genes that affect neoplasia. We will watch
how these genes change the series of normally well-coordinated gene expression events that
cause cell proliferation and transform cell fate by measuring gene expression while it happens in
living cells.
Our specific central hypothesis is that animals that do develop neoplasias have epigenetic
differences in chaperone expression that cause an increase in translation efficiency, resulting in
a higher effective gene dosage of the Ras gain of function allele, and that in turn, results in the
manifestation of neoplasia. We provide strong evidence for this hypothesis in the approach.

Public health relevance
People born with Noonan or Costello syndrome have mutations in the most common oncogene, RAS; some of these people will develop cancer. Until recent anti-HSP90 drug studies and clinical trials, RAS-driven cancers had been considered undruggable, yet these new drugs are still toxic to patients and not totally effective. We will perform a reverse genetic screen to identify genes that suppress RAS-driven hypodermal neoplasia formation in Caenorhabditis elegans, and directly observe how these potential drug targets alter the deviant program of cell division using quantitative fluorescence microscopy on live animals.